Financial Incentives and SMS to Improve African American Women's Glycemic Contro

PROJECT SUMMARY (See instructions): Among African American women with diabetes who have inadequate glycemic control (A1c>8%) who receive care in community clinics in Los Angeles County, we propose to evaluate the impact of an intervention that identifies and supports intrinsic motivation for improved diabetes control through combined in-person, phone, and SMS contact and also, for one arm of the study, a behavioral economics intervention that uses monetary incentives to reward improved glycemic control. The randomized controlled trial (RCT), a multicomponent intervention to boost intrinsic motivation for improved glycemic control will randomize patients within participating clinics to one of three groups; 1) Usual care (

Public health relevance
RELEVANCE (See instructions): Diabetes is a major public health problem that is associated with substantial health disparities for African American women compared to African American men or white men and women. This project will incorporate new technology whose use is high among African Americans (cell phone text message reminders) and strategies from the emerging field of behavioral economics to encourage and support self care behaviors that lead to improvements in diabetes control.